Effects of a telehealth exercise program for rural cancer survivors with cancer-related fatigue including integrated longitudinal assessments of objective physical function and fatty acid oxidation

PROJECT ABSTRACT
Cancer-related fatigue (CRF) is one of the most common and functionally limiting symptoms reported by cancer
survivors. While no standard of care exists for CRF management, clinically supervised exercise is one of the
best-known interventions for CRF. Exercise prescription (ExRx) for survivors, however, is currently guideline-
driven, lacking personalization and limiting overall efficacy. Rural cancer survivors experience poor health
outcomes, including increased risk of CRF, have limited access to clinical exercise programs, and stand to
benefit from improved ExRx personalization. The long-term goal of this investigation is to develop an effective
telehealth exercise program for rural cancer survivors with CRF. While many investigations of interventions for
rural survivors focus on the implementation of established services, this proposal utilizes innovative accessible
methodology to integrate assessments of exercise-associated mechanisms of CRF remediation into a clinical
efficacy trial. The purpose of these assessments is to provide the foundation for future innovations in improved
ExRx personalization, optimizing individual survivor outcomes, and to do so first in an underserved population
that stands to benefit from the outcomes. This investigation will be accomplished by pursuing three specific aims.
Aim 1 investigates the efficacy of a novel telehealth exercise program for rural cancer survivors with CRF (the
BfitBwell Telehealth Program [BfitBwell-TP]) in a randomized control trial. Rural breast and prostate cancer
survivors within five years of completing curative treatment and experiencing CRF (N=134) will be recruited into
the intervention or wait-list control group. A pilot investigation of BfitBwell-TP demonstrated feasibility,
acceptability, and similar reductions in CRF compared to the clinically supervised program upon which it is based.
BfitBwell-TP utilizes existing telehealth methodologies to deliver a combination of synchronous and
asynchronous exercise sessions paired with CRF monitoring and symptom-triggered ExRx personalization to
support CRF improvement. Aim 2 examines the effects of impaired objective physical function and fatty acid
oxidation on reduced CRF response to exercise during the intervention with integrated within-program (every
two weeks) remote assessments. Both have been associated with fatigue and both can be specifically targeted
by ExRx personalization. Recent advances have allowed the remote assessment of objective physical function
and the use of remotely collected, stable dried blood spot (DBS) samples in metabolomic analyses of impaired
fatty acid oxidation. Finally, Aim 3 explores additional biomarkers of exercise-associated CRF remediation
through the investigation of dynamic exercise metabolic profiles established during controlled, laboratory-based
exercise sessions. This Aim performs necessary work to provide the foundation for the development of remotely
assessed dynamic exercise metabolic profiles. This proposal is significant because it utilizes an accessible
intervention to reduce CRF in underserved rural cancer survivors and integrates innovative methodology to drive
continued improvement in this intervention, ultimately reducing the burden of cancer for rural survivors.

Public health relevance
PROJECT NARRATIVE The proposed investigation is relevant to public health because it focuses on establishing the efficacy of an accessible telehealth exercise intervention specifically for rural cancer survivors experiencing cancer-related fatigue. Novel methods of remotely assessing objective physical function and performing state-of-the-art metabolomic analyses are utilized to investigate exercise-associated mechanisms of cancer-related fatigue remediation first in an underserved population that stands to benefit from subsequent innovations in exercise prescription due to existing health disparities. Thus, the proposed research is relevant to the interest of the NCI Division of Cancer Control and Population Sciences in reducing the burden of cancer through improved survivorship.